GENETICS OF OBESITY RELATED SUBPHENOTYPES

The overall objective of this study is to identify genomic regions which are liked to these obesity subphenotypes. In the long term, it is planned to perform both genome-wide scanning using a standard set of anonymous markers, as well as intensified search in regions unraveled from genomic screens of other obese populations.